Leveraging population level data to inform prevention and treatment of adolescent depression following social adversities

PROJECT SUMMARY
Adverse Childhood Experiences (ACEs) are among the strongest predictors of adolescent depression and are
estimated to account for 44% of depression cases. The pervasive impact of ACEs on health has galvanized
policy makers, resulting in federal and state-wide efforts to screen for ACEs with the goal of providing
preventive services to those with high levels of ACEs. However, with 15% percent of children experiencing 4 or
more ACEs, meeting the needs of all these individuals is simply not possible given mental health care
shortages. The primary rationale for this study is that the precision and efficacy of ACEs-focused programs and
policies could be dramatically improved with better insight into what factors increase risk for, and resilience to,
depression symptoms following ACEs. The overarching hypothesis for this study is that there is significant
heterogeneity in the association between ACEs and adolescent depression symptoms that is due to
interactions between a broad range of factors. Prior investigations into such heterogeneity, however, have
faced a conceptual gap between the theories that inform adolescent depression research, which highlight
interacting, developmentally specific sources of vulnerability and resilience, and the predominant statistical
approach of testing one or two risk or promotive factors at a time. We advance ACEs and depression science
in two foundational ways: 1) we draw on empirical work and theories across disciplines to identify an inclusive
yet concise list of factors mostly likely to promote resilience or increase vulnerability to depression following
ACEs, and 2) we identify the combination of these a priori defined characteristics that most affect the ACEs-
adolescent depression symptoms association using a robust, well-powered, data driven approach (Aim 1a).
Our innovative analytic pipeline includes 10-fold replication of our primary findings, as well as replication using
alternative algorithms (Aim 1b). We also explore novel, understudied effect modifiers to generate new
hypotheses (Exploratory Aim 2). We use the longitudinal Adolescent Brain and Cognitive Development (ABCD)
study (release 6.0, available Spring 2025), which will include data on approximately 10,000 socioeconomically
and racially diverse children from 21 sites across the country with yearly data collection from age 9-10 through
age 14-15. We model effect modifiers of the association between ACEs (parent and child report) and change in
depression symptoms (assessed using the Child Behavior Checklist) between ages 9-10 and 14-15, thereby
accounting for baseline depression symptoms. A priori identified effect modifiers include sociodemographic
characteristics, family and peer relationships, media use, and pubertal timing. The proposed work will yield
robust insights about adolescents in the United States right now with implications for ACEs focused programs
and policies. Future research will replicate results in other pediatric studies, expand inquiry to adult depression
outcomes, and inform new collaborations with interventionists to design clinical trials powered to detect
heterogeneity in the effectiveness of ACEs focused treatment.

Public health relevance
PROJECT NARRATIVE Adverse Childhood Experiences (ACEs) are common and are a potent risk factor for adolescent depression, accounting for 44% of all depression cases; however, supporting all children who have experienced ACEs is a challenge that has not been met. ACEs-focused programs and policies could be dramatically improved with better insight into what characteristics lead one child to be vulnerable to depression symptoms following ACEs and another resilient. Using the large, population-based Adolescent Brain and Cognitive Development (ABCD) study and robust data driven approaches, we aim to identify what characteristics predict vulnerability and resilience to developing depression symptoms following ACEs, with the goal of informing ACEs programs, practices, and policies to improve their precision and efficacy.